COPING STRATEGIES-- FAMILIES OF CARDIAC TRANSPLANT PATIENTS DURING WAITING PERIOD

The purpose of this CLINFO ONLY study is to explore and describe perceived stress and coping strategies among families of cardiac patients during the organ waiting period - that period of time after the patient is placed on the active list for heart transplant until the actual surgery.